Stabilization of the Alveolar-Capillary Barrier with ARF6 Inhibitor as a Treatment for Severe Influenza

SUMMARY Influenza virus infection is one of the most common acute respiratory diseases and remains one of the largest disease burdens on humans, with severe primary viral pneumonia often resulting in death. The pathogenicity of influenza includes a host response that can include a severe systemic inflammatory reaction (cytokine storm) and ensuing vascular leak. Vascular leak is a fundamental element in the pathogenesis of circulatory shock and multiple organ failure, which can lead to death in influenza patients. The laboratories of Dr. Dean Li, co-­founder and former Chief Scientific Officer of Navigen, and Dr. Shannon Odelberg, along with Navigen, have demonstrated that vascular leak associated with inflammation is mediated by activation of the small GTPase, ARF6, a common nodal point in the signaling pathways of several inflammatory cytokines and growth factors. Navigen’s objective is to reduce morbidity and mortality associated with influenza infections by modifying this host response. Specifically, we propose to evaluate the efficacy of our small-­molecule ARF6 inhibitors with the hypothesis that inhibition of ARF6 will reduce vascular leak elicited by the infection while having no adverse effect on immunity-­based clearance of the virus.

Public health relevance
NARRATIVE Influenza infection remains one of the largest disease burdens on humans, with severe primary viral pneumonia often resulting in death. The pathogenicity includes a host response that can include a severe systemic inflammatory reaction and ensuing vascular leak. Navigen has demonstrated that vascular leak associated with inflammation is mediated by activation of the small GTPase ARF6 and proposes to evaluate its small- molecule ARF6 inhibitors in a mouse model of H1N1 infection.